Research Education Program for Residents and Fellows in Neurology - Porras

This Research Education Program is designed to provide teaching in the science of
investigation, in addition to protected time, structure, resources, mentoring, and research skills
training to diverse and outstanding neurology residents who will become the next generation of
leaders in clinical neuroscience research. Some unique aspects of our programs are (1) that we
are able to provide six to nine months of 80% protected time for research education and
research participation during residency; and (2) that we pair each participant with both a Senior
Mentor and a Junior Mentor who are closely engaged in the participant’s research and training.
The Hopkins environment is highly collaborative across disciplines and provides superb
research education resources, through the Clinical and Translational Science Award, the
Bloomberg School of Public Health, The Brain Sciences Institute, Neuro-ICE (Institute of
Cellular Engineering), the Kirby Functional Imaging Center, The Mind Brain Institute, and many
other interdisciplinary programs. This program is also designed to develop a diverse group of
talented and inspirational mentors who will continue to serve role models and effective coaches,
enabling residents and fellows to become independent clinician scientists with a passion for
discovery in the mechanisms of neurological disease, improving diagnosis and treatment of
neurological disease, and facilitating recovery of neurological function. We accomplish this aim
through mentoring of Junior Mentors by Senior Mentors, with structured feedback and
evaluations. To date this grant has supported exceptional residents, who all remain actively
engaged in research. Three have faculty positions in medical schools, and many of these have
obtained K08 or K23 funding. The others remain in residency or fellowship training. The
program has also been exceptionally successful in recruiting participants and Junior Mentors
from minorities that are traditionally under-represented in science. We have also been very
successful in including women both as mentors and mentees.

Public health relevance
This research education program is designed to lead residents in neurology to become outstanding clinician-scientists who will become the next world leaders in discovering how to improve diagnosis, and treatment of neurological disease. It is also aimed to refine the mentoring skills of emerging leaders in the field, so that they can continue this mission in the future.